Administrative Core

ABSTRACT
The Administrative Core (AC) supports the theme of the UNC Center for Environmental Health and Susceptibility
(UNC-CEHS): translating interdisciplinary research on environmental susceptibility to improve public
health in North Carolina. The AC provides leadership across several distinct areas, as detailed in our 5 aims.
First, the AC leads strategic planning in Environmental Cancer, Cardiopulmonary Disease, and Developmental
Disease (Aim 1). Second, the AC provides core infrastructure and research support to engage and support
environmental susceptibility research, including community engagement, molecular analysis, statistical support,
and access and support for human studies (Aim 2). Third, the AC supports recruitment and career development
of environmental health researchers (Aim 3). Fourth, the AC facilitates and disseminates research through
research reporting, engagement with community stakeholders, proposal development, publications, and
communication (Aim 4). Finally, the University of North Carolina (UNC) at Chapel Hill has a dynamic
environmental health sciences research community, and the AC supports the CEHS community by identifying
research resources and collaborators, providing administrative and scientific leadership, and facilitating fiscal
management (Aim 5). The leadership of the AC integrates expertise from different departments and Schools at
the University, providing a unified and multidisciplinary leadership perspective. Leaders come from the School
of Public Health and the School of Medicine and represent epidemiology, biostatistics, computational biology,
toxicology, environmental health sciences, genetics, clinical medicine, pathology, and analytical chemistry. Major
programmatic efforts include a formal Career Development Program, Facility Cores in Molecular Analysis and
Statistical Support (MASS), Integrated Health Sciences (IHSFC), and a Community Engagement Core (CEC).
Pilot projects are a major strategic initiative, including special targeted requests for applications (RFAs) for Team
Science and Single Investigators, a Rapid Response Seed program that is active continuously with a short
application-to-award time frame. The AC is guided in strategic planning by an External Advisory Board, an
Internal Advisory Committee, and a Stakeholder Advisory Board of community partners. The multi-directional
communication and administrative leadership provided by this core coordinates the CEHS research response to
North Carolina environmental health needs.